Administration and Biostatistics

This CORE will have responsibilities for: A. Administration of the Program Project with scientific oversight of pre-clinical scientific studies (Projects 1-3) and integration between these Projects and Core B (GLP/GMP manufacture of MGH2) and Core C (Tumor typing and neuropathologic analyses in support of culture and rodent studies of Projects 1, 2, 3). This will include organization of scientific meetings among investigators (inside and outside the Program Project) and facilitation of engendered clinical trials. B. Statistical oversight, data sharing and pre-publication review from Projects 1, 2, 3 and Cores B, C.